Characteristics and Contexts of Bystander Helping for Alcohol-Related Risk among Emerging Adults

ABSTRACT
Alcohol-related risks are highest in young adulthood and this age group is most likely to be exposed to the
alcohol use of their peers. Young adults are also highly influenced by their peers, both for high-risk behaviors
and for prosocial actions. Bystander helping is one way that peer influence in potentially dangerous alcohol
consumption circumstances can reduce harm to those at risk. Bystander helping is the phenomenon when
witnesses to a problematic event step in to intervene in some way, but bystander helping has been under-
investigated when hazardous alcohol use is the target behavior. In order to develop interventions that
effectively leverage peer influence for harm reduction in the young adult community, research must be
conducted on the circumstances of alcohol-related events, and specifically the experiences of those who could
be bystander helpers. Drawing from bystander intervention research on sexual assault and bullying prevention,
we propose to investigate the contexts and conditions under which bystander helping for hazardous alcohol
use occurs naturalistically. The aims of this research are to investigate the event-level (Aim 1) and individual
difference (Aim 2) predictors of bystander helping in response to peer alcohol-related risk, and to investigate
the relationship between helping approaches and bystander and peer outcomes (Aim 3). Following community
engagement with an advisory group and a pilot phase in which we will finalize procedures and assessments,
we will conduct an assessment study with a sample of young adults (N = 200; ages 18-25) balanced on gender
and reflecting the US in race/ethnicity, who will report on their exposure to the hazardous drinking of others in
their environment for 28 days using ecological momentary assessment (EMA) methods. Participants will
complete random and morning reports on their own smartphones that will collect information about alcohol-
related behavior witnessed, the social context, the characteristics of the person showing the risk behavior, the
nature of the relationship between that person and the bystander, the bystander’s own state including their own
level of intoxication, perceived barriers to intervention, bystander strategies used, outcomes of any bystander
helping, and the outcomes to the person showing the hazardous behavior. Each evening survey will pull
forward information from the previous survey to allow for assessment of subsequent observations, and
morning surveys will assess further the risks observed, behavioral responses, and outcomes. Methods used
during the baseline assessment and orientation, including a social network interview, will facilitate brief,
accurate and private EMA reports. We expect the information derived from this investigation will contribute in a
substantive way to the development of effective trainings for individuals who are exposed to the hazardous
drinking of others.

Public health relevance
PROJECT NARRATIVE The proposed study will investigate bystander helping in hazardous alcohol situations among young adults. For 28 days participants will complete mobile phone assessments on days that they are exposed to another person’s hazardous alcohol use. This research will provide invaluable information about event- and person- level characteristics that are associated with bystander helping, as well as how the specific helping approaches bystanders use are related to situational outcomes.